Creating, evaluating, and sharing synthetic data for multinational HIV cohorts

Project Summary/Abstract
Principles of open science often clash with requirements of data privacy laws and organizational policies,
especially with respect to sensitive health data. This conflict has become particularly evident in international
HIV research, which often relies on observational cohort data. Currently, researchers cannot publicly share HIV
cohort data (e.g., post on a publicly available website) and therefore many of the benefits of open science
cannot be realized, such as enabling the reproducibility of published findings and creating opportunities for a
larger number of people to study the data and contribute scientific discoveries. Data privacy methodologies
developed for data sharing often lower the fidelity of the data to reduce the risk of re-identification, but they still
preserve the linkage between records and real people. Synthetic data generated by computer simulation, by
contrast, offer a more desirable solution as they can resemble the characteristics of the original data while
severing the linkage between records and real people. Though synthetic data can never fully replace the
original data, they can benefit science. However, based on preliminary work, existing methods for generating
synthetic data are insufficient to generate synthetic HIV cohort data that closely resemble the original data. In
this project, we will adapt and apply state-of-the-art artificial intelligence methods for generating synthetic data
that are tailored to longitudinal observational HIV cohorts. We will apply these methods to create synthetic data
intended to mimic data from two multinational HIV cohorts: the Caribbean, Central and South American
network for HIV epidemiology (CCASAnet) and the East African region of the International epidemiology
Databases to Evaluate AIDS (IeDEA-EA). These cohorts are composed of hundreds of thousands of people
living with HIV. We will evaluate the quality of our synthetic data using both intrinsic (e.g., proportions,
distributions, correlations between variables) and extrinsic comparisons to the original data. Extrinsic
comparisons will be performed by a research advisory board of HIV investigators who will select comparative
HIV studies independent of the data generation process. We hypothesize that the synthetic data will be useful
for hypothesis generation, and these extrinsic comparisons will provide evidence supporting or refuting this
hypothesis. We will also study potential ethical, legal, and social (e.g., perception, discomfort) barriers to
sharing synthetic HIV cohort data through qualitative studies among people involved in HIV cohort studies
(e.g., investigators, administrators, and patients). Finally, we will develop software toolkits so that others can
generate synthetic HIV cohort data.

Public health relevance
Project Narrative This project will develop computational techniques and software tools for generating synthetic HIV cohort data to enable broad data sharing while upholding the privacy of the real data upon which they are based. These techniques and tools will then be applied to generate large synthetic multinational HIV cohort data mirroring original data from Latin America and East Africa. We will investigate the extent to which such synthetic HIV cohort data enable the generation of hypotheses that yield results similar to those using real data.